Biochemical Classification of Cancer Missense Mutations in the Retinoblastoma Protein

Project Summary/Abstract
The overall objective of this research is to characterize the structural mechanisms by which cancer
mutations deregulate the retinoblastoma tumor suppressor protein (Rb). Rb is a multifunctional hub protein that
facilitates protein-protein interactions in order to carry out various functions related to cell growth and chromatin
regulation. Recent cancer genome sequencing data have highlighted sites of recurrent somatic and germline
missense mutations, the majority of which occur to the highly-conserved pocket domain. A detailed molecular
understanding of the direct structural and functional consequences of these mutations is key to parsing the
mechanisms by which Rb deregulation occurs in cancers, as well as a first step toward identifying strategies to
therapeutically restore loss of Rb function in cancer patients.
The overall objective of this research will be achieved through two aims, which together will generate
complete structure-function profiles for each of the 59 recurrent clinical missense mutations to the pocket domain
of Rb. The goal of Aim 1 is to study Rb mutants as purified proteins in biochemical assays that characterize
which protein-binding functions are perturbed by which mutations. To achieve this goal, a differential scanning
fluorimetry (DSF) assay has been developed for use with Rb and protein interaction partners, which diagnoses
changes to fold stability and protein-protein interactions that arise as a consequence of mutations. These assays
will be further supported by data generated using fluorescence polarization (FP), isothermal titration calorimetry
(ITC), and differential scanning calorimetry (DSC). Together, multiple biophysical parameters will be measured
for each mutant; including, protein melting temperatures, Gibbs free energy of unfolding, and dissociation
constants for multiple protein binding partners. The goal of Aim 2 is to reveal the structural basis of cancer
mutations to Rb using protein x-ray crystallography. The hypothesis is that the mutations deregulate Rb through
various structural mechanisms, including: the direct disruption of critical protein binding interfaces, negative
allosteric regulation of protein binding interfaces, and overall changes to the stability of the pocket domain fold.
A thorough understanding of the structural aspects underpinning the mechanisms by which mutations deregulate
Rb will provide a solid basis for rational approaches to restore its function.

Public health relevance
Project Narrative Inactivation of the retinoblastoma tumor suppressor protein (Rb) is a common event in many types of cancers, yet to-date there have been no therapeutics developed that target Rb for the treatment of cancer. This research will identify structural and biochemical mechanisms of Rb inactivation that result from clinical recurrent missense mutations. Results of this research which will inform on functional outcomes of clinical mutations and provide high quality models to enable strategies to restore the loss of Rb function in cancer patients.